Project 2: Maximizing Retailers' Responsiveness to FDA Regulatory Autho

For over 20 years most tobacco industry expenditures for advertising and promotions have been focused on the retail environment (FTC 2012 a, b,). This has been especially true in vulnerable communities heavily targeted by the tobacco industry. To correct this disparity, we need to understand the retail environment among vulnerable populafions; since the enactment in 2009 of the Family Smoking Prevenfion and Tobacco Control Act (The Act) giving the Food and Drug Administration's (FDA) regulatory authority. For this reason, the specific aims of Project 2 are: 1) to examine knowledge, attitudes, beliefs and behaviors of small independent retailers in vulnerable communities regarding compliance with FDA; 2) to examine opfimal non- tradifional ways (social media sites, online videos, text messaging, blogs, smartphone applicafions, wireless communicafion, Facebook, Twitter, use of cell phones (iPhones, Blackberry), and other mobile channels; and the confluence of traditional broadcast media, with voice and written communication and the Internet) that FDA can use to communicate with retailers and the public in vulnerable communities of predominantly African Americans (AA), Hispanic/Latinos (H/L), Koreans (K); and American Indians (Al); and 3) to examine factors that influence key community informant's public perception of the FDA as a credible source of tobacco product informafion in these communities. Using the Socio-ecological Model (SEM) as a backdrop, community based participatory principles, and engaging community lay health care workers and a cadre of promotores de salud (health promoters) in the conduct of the research, we will focus on the retail environment and on opinions from key community leaders in vulnerable minority communifies engaged in this study. We will randomly select our sample from listings of the Board of Equalization, which contains 38,000 retailers in California with a license to sell tobacco, and based on Census tracts in vulnerable neighborhoods in the Greater Los Angeles area and beyond. Our key opinion leaders sample will be drawn from listings of community stakeholders that form part of tobacco control coalitions and organizations working with these vulnerable populafions in California. We will conduct 16 focus groups (N=192), a retailer survey (N=600) (200 H/L, 200 AA, 100 K, 100 Al), store observafions (200), and GIS/Environmental scans to respond to aims and determine retail density in vulnerable communities. We will analyze data, write periodic reports, manuscripts for scientific publications and share data with FDA, other TCORSs, and stakeholders. RELEVANCE (See instmctions): Project 2 addresses FDA priorities 5 (Communicafions) and 7 (Policy) and the following quesfions: 1) What are the knowledge, attitudes and beliefs of retailers and key opinion leaders about tobacco products and FDA tobacco product regulatory authority, and barriers to compliance with regulations? 1) What are the most effective messages and non-tradifional modes of communicating with retailers regarding FDA's regulatory authority? 3) What are vulnerable community percepfions of the FDA as a credible source of tobacco information; and optimal modes of communicafing? Findings will be crifical for the FDA to maximize compliance with regulations.